Development of Blood Based Diagnosis of Parkinson's Disease

PROJECT SUMMARY/ABSTRACT Parkinson's disease (PD) is a devastating neurodegenerative disorder which has no cure or disease-modifying therapy. One of the greatest obstacles for developing a disease-modifying therapy for PD is the lack of early diagnosis. To date, there is no definite, sensitive and predictive laboratory test available that can identify individuals well before they show clinical manifestations. The availability of early diagnosis of PD would be of utmost importance for the development of a disease-modifying or preventive therapies before the irreversible brain damage has already occurred. The pathological hallmark of PD is the cytoplasmic deposition of amyloid- like aggregates mainly composed of alpha-synuclein (αSyn) termed as Lewy bodies. Compelling evidence suggests that the central event in PD is misfolding and aggregation of αSyn. The misfolding and aggregation of αSyn follows a nucleation-dependent mechanism which involves the formation of several intermediate species including soluble αSyn oligomers and protofibrils. Alpha-synuclein oligomerization is a key event in PD pathogenesis that begins years or decades before the appearance of clinical signs. Most importantly, recent studies have suggested that these αSyn oligomers circulate in biological fluids such as cerebrospinal fluid (CSF) and blood. Thus, we hypothesize that the detection of these circulating misfolded αSyn oligomers holds promise for diagnosis of PD and related synucleinopathies. We have recently reported protein misfolding cyclic amplification (PMCA) assay for the detection of misfolded αSyn oligomers in CSF. Using this PMCA technology, we have been able to differentiate PD patients from control individuals affected by other neurodegenerative (ND) or non-neurodegenerative (NND) disorders with high specificity and sensitivity. The main goal of this application is to expand the applicability of this technology to detect small amounts of αSyn oligomers present in blood so that a cheap, noninvasive and reliable diagnostic test could be developed. To achieve this goal, we will optimize the assay conditions for sensitive and specific detection of αSyn oligomers in human blood plasma. Then, we will use well- characterized plasma samples from PD patients, individuals affected with other synucleinopathies, and healthy controls. Next, the sensitivity and specificity of αSyn-PMCA for PD will be evaluated using a large number of plasma samples from PD patients, age-matched healthy controls, and individuals affected from ND and NND. Finally, we will attempt to correlate the kinetic parameters of αSyn-PMCA with clinical data at different stages of PD. The findings obtained here will lay the foundation for the development of low cost, non-invasive diagnosis of individuals at risk of developing PD and other synucleinopathies. Our findings will not only help to understand the mechanisms implicated in PD progression but also will provide a window for disease prevention and intervention.

Public health relevance
PROJECT NARRATIVE To date, there is no definite, sensitive and predictive laboratory test available that can identify individuals at risk of developing Parkinson’s disease (PD) before they show clinical manifestations. Recently, we have reported misfolding cyclic amplification (PMCA) assay for the detection of misfolded αSyn oligomers in CSF that can easily differentiate PD patients from controls with high specificity and sensitivity. The main goal of this research proposal is to optimize and evaluate PMCA for the detection of small amounts of αSyn oligomers present in human blood so that a cheap, non-invasive and reliable diagnostic test could be developed.